Harmonizing Multiple Data Sources And Psychological Autopsy To Characterize Suicides Among Opioid-Related Deaths

Project Summary/ Abstract
This Mentored Patient-Oriented Research Career Development Award is designed to provide the applicant
with the advanced training necessary to establish an independent program of research in the epidemiology of
overdose mortality and suicide. A comprehensive training program is proposed, combining formal coursework,
mentoring, and hands-on training experiences designed to develop expertise in data linkage/ harmonization,
latent class modeling (LCA), qualitative psychological autopsy (PA) and mixed methods research.
As overdose deaths increase, they continue to be treated as accidents resulting from changes in opioid use.
However, epidemiologic research suggests that many of these deaths are likely suicides, This has important
implications for appropriately targeting interventions. We will measure the magnitude of this misclassification of
manner of death (MOD; intentionality) and identify factors that may guide medical examiners to more
accurately classify suicide decedents. We hypothesize that approximately one third of opioid related deaths of
undetermined manner are truly suicides, and that LCA can distinguish subgroups of decedents with greater
likelihood of suicidal intent. We will use PA in a subset of previously undetermined intent decedents to test
predictive ability of empirically-derived classes and characterize the diverse paths to overdose.
We propose to analyze all opioid overdose deaths in Maryland from 2006-2019 (n=13,861) using demographic,
social, and clinical data which we will link from the Maryland Suicide Data Warehouse to mortality data from
the Office of the Chief Medical Examiner (OCME). First, taking one third of this sample, we will compare cases
classified as suicidal (n=115) from accidental (n=756) and undetermined intent (n=3,748) using a three-way
multinomial logistic regression. Next, variables found to be most salient comparators will be used in LCA of the
remaining cases, agnostic of OCME MOD class (n=9,286). Comparing the empirically derived classes with the
OCME designations, we will assess the proportion of designated suicides and accidents in each class. Finally,
from each of these latent classes, we will select 40 decedents designated by OCME as ‘undetermined manner’
to be further examined by multiple collateral interview PA, to corroborate these latent classes. By generalizing
findings from LCA and PA, more accurate suicide rate estimates can be made. Findings would impact future
MOD designation and potentially, how prevention interventions target accidental overdoses and suicides.
Training and mentorship plans will leave the candidate well positioned to become an independent physician-
epidemiologist, able to utilize both qualitative and quantitative methods for the validation of large linked data
sets describing the interrelated suicide and overdose crises. His long term career goals include the elucidation
of mechanisms of self injury mortality, the use of mixed methods for the generation and investigation of novel
hypotheses regarding pathways to suicide, and the ability to translate these findings into suicide prevention.

Public health relevance
Project Narrative Many of the individuals who die by suicide are not clearly identified as such by Medical Examiners, and their causes of death are often categorized as undetermined with implications for state and national statistics of suicide and for understanding of the causes of suicide and accidental death. The proposed study aims to improve detection of suicide deaths by using large linked data sets, latent class analysis and psychological autopsy to better distinguish suicide among decedents whose cause of death is currently categorized as “undetermined” and to pinpoint variables that can be used to better identify such cases. In addition to improving the statistics of suicide at state and national level and identifying characteristics that will aid Medical Examiners in identifying suicide and accidental overdose deaths, the study will contribute to a better understanding of real world relationship between drug use and suicide and their impact on individuals, families, peers and society, as highlighted in NIDA’s current Strategic Plan.